Regulation and Function of RAB7 in the pulmonary endothelium

Pulmonary arterial hypertension (PAH) has a 3-year mortality rate of up to 55%. The survival benefit of
vasodilator therapy does not last beyond one year, indicating that pulmonary artery (PA) remodeling, rather than
vasoconstriction, predicts long-term prognosis. New anti-proliferative therapies emphasize targeting PA
remodeling in PAH. A better understanding is needed of how ECs create an abnormal microenvironment that
promotes PA remodeling. This proposal aims to fill this crucial knowledge gap by elucidating a novel
mechanism by which ECs profoundly impact other PA mural cells.
The discovery that the endosomal GTPase RAB7 is a critical gatekeeper for lung EC and vascular function
forms the foundation of this work. However, the molecular regulation of RAB7 expression in ECs in PAH and the
mechanism by which endothelial RAB7 deficiency induces pulmonary hypertension (PH) remain unclear. Here,
studies are proposed to address these two critical issues. Based on new supportive data, the unique paradigm
is presented that hypoxia signaling represses endothelial RAB7 transcription in PAH, promoting PA remodeling
and PH via an altered secretome. Exciting new data reveal MEIS2 as a new transcriptional inducer of RAB7
in ECs. Additionally, a previously unknown repression mechanism is shown where hypoxia-inducible factor (HIF)-
2α accelerates MEIS2 mRNA decay via microRNA (miR)-199a. Unbiased screening identified a new interaction
between RAB7 and the RNA-binding protein cold shock domain containing E1 (CSDE1) in ECs. The loss of
RAB7:CSDE1 interaction upregulated target mRNAs via CSDE1, subsequently increasing their levels in
the secretome and promoting PH via the proliferation of PA smooth muscle cells (PASMCs) and PA adventitia
fibroblasts (PAAFs). Notably, the FDA-approved CSDE1 modulator Clofoctol reduced experimental PH.
These results led to the HYPOTHESIS: In PAH, the transcriptional repression of RAB7 in ECs arises
from accelerated decay of MEIS2 mRNA via the HIF-2α→miR-199a pathway and leads to the CSDE1-
dependent dysregulation of the endothelial secretome, which contributes to PH. This hypothesis will be
tested with the two SPECIFIC AIMS: Aim 1. To determine the MEIS2-driven transcriptional regulation of
RAB7 in ECs. Aim 2. To investigate the molecular mechanism of RAB7-dependent PA remodeling via
CSDE1 in ECs. In vitro experiments using gene manipulation, co-culture experiments, in vivo rat and mouse
experiments, and Omics approaches will be employed to test the hypothesis. This research will establish a new
molecular model connecting RAB7 transcriptional regulation via the HIF-2α→miR-199a→MEIS2 axis to EC
dysfunction and PAH. This approach will further elucidate for the first time the molecular link between RAB7
deficiency, mRNA stability, PASMC and PAAF growth, and PA remodeling by studying CSDE1 as a key regulator
of the endothelial secretome. These results will fundamentally enhance the understanding of EC dysfunction in
PAH and provide novel therapeutic opportunities.

Public health relevance
Narrative The proposed research is relevant to public health because identifying the mechanisms of endothelial dysfunction and vascular remodeling in pulmonary arterial hypertension is ultimately expected to understand this devastating disease further. The investigation of the regulation of RAB7 expression in the lung endothelium and a new mechanism by which endothelial RAB7 modulates pulmonary artery remodeling, as outlined in the proposal, will contribute new data that will aid in developing novel and more mechanistic treatment approaches to reduce morbidity and mortality of patients with pulmonary arterial hypertension. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge to help reduce human disease burdens, particularly cardiopulmonary disease.